Rapid Antigen Test for Diagnosis of Active HCV Infection

Summary/Abstract
Hepatitis C virus (HCV) causes a global epidemic with 71 million people infected. HCV is a blood-borne
flavivirus that can cause cirrhosis and liver cancer and is responsible for ~400,000 deaths each year. Direct-
acting antivirals (DAAs) can effectively cure HCV infection; however, most infected individuals are unaware of
their infection status or only receive treatment after severe liver damage. Moreover, DAAs are cost-prohibitive
and do not reach at-risk populations including people living in low- and middle-income countries or injecting
drug users. Consequently, the number of yearly new infections (~1.4 million) exceeds the number of people
receiving treatment (~650,000), thereby exacerbating the epidemic. Elimination of HCV by 2030 – a goal set by
the World Health Organization (WHO) – will require multifaceted, decentralized public health prevention
strategies. One such strategy calls for the development of point-of-care assays for active HCV infection, which
is expected to accelerate the diagnoses of individuals who are most likely to transmit the virus and link those
infected to care. As such, this proposal aims to develop a low-cost, instrument-free rapid antigen test for active
HCV infection. We recently immunized mice with the HCV core antigen (HCVcAg), a protein secreted into the
blood that can be detected almost simultaneously with HCV RNA during an active infection. Using flow
cytometry, we sorted HCVcAg-specific B cells from immunized mice, then sequenced the antibody variable
segments, and cloned and recombinantly expressed monoclonal antibodies (mAbs) that target the HCVcAg. In
Aim 1, we will characterize the binding kinetics of the HCVcAg-specific mAbs. The mAbs with the most robust
binding kinetics will then be used to generate a rapid antigen test. In Aim 2, we will determine the analytical
and clinical sensitivities and specificities of the rapid antigen test using recombinant proteins, native viruses,
and cryopreserved, de-identified serum/plasma previously collected from HCV viral load positive and negative
patients and healthy controls. Our rapid antigen test is expected to have a sample-to-result processing time of
<20 minutes and a maximum manufacturing price per test of <$4 USD. The successful completion of this
project will lead to one of, if not the first, cost-effective, instrument-free rapid antigen test for the point-of-care
diagnosis of active HCV infection.

Public health relevance
Narrative Hepatitis C virus (HCV) infection affects 71 million people and causes ~400,000 deaths yearly; however, global estimates indicate that a majority of those infected with HCV are not aware of their infection status and remain untreated. In this proposal, we will characterize the binding kinetics of monoclonal antibodies against HCV, and use them to develop and evaluate a low-cost, instrument-free rapid antigen test for active HCV infection. The proposed rapid antigen test will accelerate the diagnosis of individuals who are likely to transmit the virus and link those infected to care, thereby helping to alleviate the global burden of HCV infection.